Improved Spatial Resolution in Magnetoencephalography with an Optically Pumped Magnetometer Array

Project Summary/Abstract The fixed helmet design of commercially available magnetoencephalography (MEG) systems utilizing superconducting quantum interference device (SQUID) magnetometers is designed to fit the 95th percentile of head size and therefore gives suboptimal measurements of the MEG signals for most subjects, especially children. A small head size will result in a gap between the helmet and head of several centimeters, and since the MEG signal amplitude decays as 1/r3, where r is the distance from the neuronal source, this large gap can result in signal attenuation by a factor of ~10. Therefore, placing the sensors on to the head will lead to increases in signal amplitude. Additionally, if sensors are placed on or near the scalp, high spatial frequency variations in the magnetic field will be detectable. Combining these factors, substantially improved spatial resolution in localizing neuronal sources will be enabled. Recent developments in sensor design now makes optically pumped magnetometers (OPMs) ideal for application to the field of MEG, and since they operate above room temperature and can be constructed as individual sensor modules, the sensor layout can be flexible. The long-term goal of this research is to develop a full-head MEG system based on OPMs that can conform to any head size to give the largest possible signal while at a reduced cost compared to cryogenic MEG. The objective of this proposal is to develop a 72-channel OPM MEG system giving partial head coverage to demonstrate improved spatial resolution in the measurement of nearby neuronal sources within the human brain. The system will be rapidly reconfigurable to concentrate the array coverage on an area of interest. Our central hypothesis is that the close proximity of the OPM array will allow a new level of spatial resolution for MEG. In Specific Aim 1, our current OPM-based MEG array with 20 channels will be expanded to a reconfigurable 72-channel system. The reconfigurable array will accommodate varying head sizes, particularly that of small adults and children, and the number of sensors will allow the array to be concentrated over two sections of the brain simultaneously. In Specific Aim 2, analysis techniques specific to the reconfigurable array will be developed. When the array is repositioned for each new subject, real-time array calibration is required for accurate magnetic source localization and external noise suppression. In addition, data simulation will optimize the positioning of the array and reveal the possible improvements in source localization due to access to signals of higher spatial complexity. In Specific Aim 3, the source localization precision between our OPM MEG array and a commercial SQUID-based MEG array will be compared. Tasks involving auditory and visual stimulation will allow us to study spatial variation of brain activity due to changing stimulus parameters. With the expected improvements in signal size and spatial resolution, higher fidelity MEG measurements for people of all head sizes ranging from premature infants to the largest adults are enabled, with broad ranging applications in neuroscience and in understanding and treating brain dysfunction.

Public health relevance
Project Narrative Functional imaging of the human brain is critical to our understanding of the healthy brain and to gain insights into the underlying causes of brain dysfunction across the life span. Magnetoencephalography (MEG) is an invaluable tool for functional neuroimaging because it can directly measure neural activity with sub-centimeter spatial resolution (better than electroencephalography) and millisecond temporal resolution (better than functional magnetic resonance imaging (fMRI)), and optically pumped magnetometers now allow MEG sensor arrays to conform to the shape of head, increasing sensitivity to higher spatial frequencies of the measured signals, which will allow for improved spatial resolution of the MEG measurements approaching that of fMRI. Our goal is to realize this improved spatial resolution with a conformal MEG array, which could lead to improved presurgical localization of affected brain areas, new discoveries in degenerative brain disorders, improved understanding of normal brain dynamics, and dramatically improved MEG measurements for pediatric patients for potential early identification of developmental disorders.